Mitochondrial liquid-liquid phase separation in Alzheimer's disease

PROJECT SUMMARY
In Alzheimer's disease, abnormalities in the morphology, transport, and functions of mitochondria are
prevalent. Mitochondria are cellular organelles that generate energy to fuel cellular metabolism. Toxic Aβ42 is
known to concentrate in mitochondria. However, how Aβ42 affects crucial mitochondrial processes that
maintain mitochondrial health is still unclear. The long-term objective is to contribute to developing mechanism-
based treatment strategies for Alzheimer's disease. The overarching goal of this application is to identify the
mechanisms responsible for Aβ42's effects on the regulation of mitochondrial gene expression after
transcription and mitochondrial dysfunction in a basic cell model. The central hypothesis is that Aβ42 interferes
with mitochondrial liquid-liquid phase separation, causing morphological and functional mitochondrial defects in
Alzheimer's disease. The rationale for the proposed research is that a mechanism-based determination of
Aβ42's role in mitochondrial dysfunction will provide new opportunities for developing novel strategies to
intervene in Alzheimer's disease. To attain the overall objective, the following two specific aims will be pursued:
(Aim 1) Investigate the impact of Aβ42 on mitochondrial ribonucleoprotein granule dynamics in mitochondria.;
(Aim 2) Optogenetic control of Aβ42 and mitochondrial ribonucleoprotein granules in mitochondria. At the
completion of these aims, this project will provide insights into how to maintain mitochondrial health by
modulating the mitochondrial liquid-liquid phase separation in Alzheimer's disease.

Public health relevance
PROJECT NARRATIVE The increasing elderly population and prevalence of dementia are a significant burden on American society. A detailed understanding of how mitochondria-localized Aβ42 contributes to the pathophysiology of Alzheimer’s disease is expected to provide a framework for the subsequent identification of novel preventive or treatment strategies.